Mechanisms of heavy metal-induced disease and therapeutic strategies

PARENT AWARD SUMMARY
Our vision for the University of New Mexico Health Science Center (UNM) Clinical and Translational Science
Center (CTSC) is to be an essential part of tightly integrated networks. The resulting collective synergy will
catalyze transit of therapeutic, diagnostic, and preventative interventions; disseminate innovative translational
research methods and best practices; and lead informatics standards and policy development to promote shared
resources and clinical and translational research (CTR). We will accomplish this by providing tailed resources to
accelerate translation, which will be harmonized with other CTSA hubs, including for example: multi-site study
support, regulatory support, research design, workforce training, and integrated informatics support. Our focus
will be to advance the full spectrum of both clinical and translational research and science (CTR/S). So that our
impact is clearly demonstrated, we also propose meaningful, measureable goals and outcomes. The UNM CTSC
offers a unique setting to achieve this vision and to catalyze high quality CTR/S. One of four majority-minority
states, New Mexico is ethnically diverse (Anglo, Hispanic, Native American), rural, and medically disenfranchised
with health-disparate populations. Our state presents geographic, racial/ethnic, and rural obstacles to health care
and outcomes and is among only five of 24 IDeA states with a CTSC hub. A key element of our CTSC is
continuous improvement and learning in order to translate what we know into what we do. In order to achieve
this, we will continue to build and enhance synergy among new technological capabilities, catalyze opportunities,
and effect institutional policy change. Through the following five strategic aims, we are poised to play a leadership
role in our state and region while being a significant asset to and partner in the CTSA consortium: 1) Align the
governance, leadership, and strategic planning of the entire UNM health system, its partners, and its academic
enterprise with the CTSC and CTR/S; 2) Engage in beneficial collaboration and partnerships; 3) Use our initial
success in education and training to build the translational workforce of tomorrow; 4) Develop and disseminate
innovative and streamlined research resources (including data and informatics), methods, and processes with a
focus on quality and efficiency; 5) Integrate translational science across its multiple phases and disciplines within
complex populations and across the lifespan. With our CTSC as the catalyst, our expected outcomes are to a)
improve health through continuous input, innovation, and learning; b) speed the development and use of new
diagnostics, therapeutics, preventative interventions; and c) focus on complex and special populations in our
state and region, including those that are rural, underserved, and diverse across the continuum of lifespan.
PROJECT SUMMARY
Gadolinium (Gd)-based contrast agents cause the sometimes-lethal and often debilitating ‘nephrogenic’
systemic fibrosis (NSF). The unique physical and chemical properties of lanthanide element Gd render the heavy
metal highly indispensable for diagnostic magnetic resonance imaging (MRI) and targeted nanoscale therapies.
Following exposure to these MRI contrast agents, Gd-accumulation has been demonstrated in target organs,
including the kidney, skin, liver, and nervous system of patients (many with normal renal function). Around 50%
of all MRI exams are enhanced with gadolinium. There is a distinct correlation between environmental Gd
concentrations and the level of healthcare systems as excess Gd levels are found in proximity to large cities with
hospitals performing MRI. Gd-chelates are not as stable as anticipated as many patients report a diverse range
of symptoms attributed to previous gadolinium exposures. Our research team has established a well-
characterized rodent model of gadolinium-induced disease. We were the first to report the in vivo formation of
nanostructures resulting from systemic treatment with magnetic resonance imaging contrast agents.
Investigations into the complexities of retained gadolinium are limited. Defining the biological effect of this
lanthanide is paramount.
This supplement will focus on defining gadolinium-induced cellular and molecular perturbations aimed at
developing safe and effective therapies to mitigate complications of lanthanide-induced diseases. This goal will
be accomplished by developing a methodical understanding of how heavy metal gadolinium interacts with
biological membranes, leads to cytotoxicity and how prophylactic or post-hoc use of therapeutic targets can
attenuate Gd retention. This supplement will provide us with the ability to examine the impact of heavy
metal retention on cellular processes, identify therapeutic targets, and provide a foundational
understanding of gadolinium-induced toxicity. Identifying such methods and therapies align with the
University of New Mexico Health Sciences Center Clinical and Translational Sciences Center Parent Award.

Public health relevance
PROJECT NARRATIVE RELEVANCE Healthcare systems often fail to recognize the deleterious impact of gadolinium retention in patients following exposure to magnetic resonance imaging (MRI) agents. Many patients seek off-label metal-chelation therapies. The proposed research aims to define the intracellular mechanisms by which gadolinium induces disease. These results are expected to have a beneficial impact and will influence the development of therapeutic targets for lanthanide-induced diseases and possible treatments for gadolinium retention.